Engineering designer probes for imaging membrane potential: novel parts, architectures, and platforms

Project Summary/Abstract
The mammalian brain is composed of a diverse array of neuronal and glial cell types that differ in their
morphology, electrical characteristics, and molecular markers. Understanding the neural basis of behavior
in health and disease will, therefore, require elucidation of the respective roles of these cell types in
representing and processing information. However, traditional electrophysiological (electrode-based)
methods for monitoring neural activity cannot be restricted to specific cell types. The solution suggested in
this proposal is to develop improved Genetically Encoded Voltage Indicators (GEVIs), which are
fluorescent proteins whose brightness is modulated by electrical activity (voltage). GEVIs are promising
tools as their expression can be restricted to genetically-defined cell populations. Moreover, by directly
reporting voltage rather than a surrogate parameter (e.g. calcium), they can monitor a richer repertoire of
neuronal electrical signals, including inhibitory signals (hyperpolarizations), subthreshold depolarizations,
and rapid trains of action potentials.
While GEVIs have shown early promise for optical detection of voltage transients, their
performance is currently insufficient for single-trial imaging of voltage in populations of individual neurons
in vivo. This proposal aims to address this performance gap using a multipronged approach. First, the
authors propose to optimize a new GEVI architecture optimized for long-term in vivo imaging. Second,
natural diversity will be mined to uncover novel voltage-sensing proteins that enable detection of voltage
dynamics with more sensitivity or temporal precision. Finally, a new high-throughput screening platform
optimized for engineering GEVIs will be deployed for rapidly screening large libraries of indicators. To
facilitate deployment in downstream applications, GEVIs with improved properties will be
comprehensively evaluated across all key performance metrics in neurons, in brain slices, and in vivo.
Overall, the experiments are anticipated to lead to designer GEVIs of broad utility and impact for
understanding how the various cell types in the brain cooperate to enable behavior.

Public health relevance
Project Narrative Imaging brain activity is necessary for understanding how the brain functions, and what goes awry in disease. However, existing brain imaging techniques are limited by their low temporal or spatial resolution and/or by an inability to only image specific types of brain cells. The authors of this proposal are developing new fluorescent probes of neural activity to address the limitations of existing tools.